(PQ9) A NOVEL MECHANISM OF PACLITAXEL-INDUCED PERIPHERAL NEUROPATHY AND POTENTIAL TREATMENT

Project summary Paclitaxel-induced peripheral neuropathy (PIPN) and associated neuropathic pain is the most common and serious adverse effect experienced by cancer patients accepted paclitaxel infusion, which adversely affects daily activities and thereby quality of life, and sometimes forces the suspension of treatment, negatively impacting survival. However, mechanisms underlying the pathogenesis of PIPN are uncertain, which hinders the development of effective therapies for this comorbidity. The proposed studies attempt to identify molecular mechanisms underlying PIPN, as well as a potential therapeutic target to prevent the development of PIPN and neuropathic pain. Excessive neuronal excitation is a primary source of PIPN. Our preliminary data indicate that the hyperexcitability of primary sensory neurons might result from paclitaxel-induced inhibition of KCNQ/Kv7 channels, which are abundant in sensory neurons and axons. Retigabine, an FDA-approved drug that opens KCNQ/Kv7 channels, could be a plausible treatment to reduce paclitaxel-induced pathology and symptoms. We hypothesize that paclitaxel induces peripheral neuropathy and chronic pain by inhibiting KCNQ/Kv7 channels and exciting primary sensory neurons, activating KCNQ/Kv7 channels during chemotherapeutic agent infusion may thus prevent the development of PIPN. In this project, we will produce PIPN in adult, tumor-free rats or mice, and utilize techniques of immunohistochemistry, electrophysiology, electron microscopy, and behavioral testing to test three important predictions: 1) Paclitaxel excites primary sensory neurons by inhibiting KCNQ/Kv7 channels. Paclitaxel-induced effects on KCNQ currents in CHO cell lines in which KCNQ2/3 are overexpressed, as well as its effects (KCNQ currents and membrane potential) on DRG neurons from naïve rats, Kcnq2fl/fl//Pax3-Cre, Kcnq3-/-, and their littermate control mice will be assessed electrophysiologically (in vitro recording); 2) Paclitaxel induces peripheral neuropathy and chronic pain by inhibiting KCNQ/Kv7 channels. XE-991, a selective KCNQ/Kv7 channel blocker, will be delivered to naïve rats to see whether XE-991 can simulate PIPN and chronic pain. The role of KCNQ/Kv7 channels in PIPN will then be evaluated by exposing of Kcnq2fl/fl//Pax3-Cre, Kcnq3-/-, and their littermate control mice to paclitaxel. Pain-related behavior, morphological alterations (gliosis in the spinal cord, IENF in the skin, ROS in DRG neurons, mitochondria and microtubules in nerve sections), and neuronal excitability will be assessed; 3) Combining retigabine with paclitaxel can prevent the development of peripheral neuropathy and neuropathic pain. Retigabine will be given to rats during the exposure to paclitaxel. The excitability of DRG neurons, gliosis in spinal cord, IENF in the epidermis, and pain-related behaviors will be measured. Finally, the chemosensitivity of a breast cancer tumor to paclitaxel will be assessed in the presence of retigabine. These studies may lead both to a better understanding of the causes of PIPN as well as delineate novel targets for therapeutic development.

Public health relevance
Narrative/Public Health Relevance Paclitaxel-induced peripheral sensory neuropathy (PIPN) accompanied by neuropathic pain is particularly severe and is often a limiting factor in treatment for cancer patients receiving paclitaxel infusion. However, mechanisms underlying the pathogenesis of PIPN are uncertain, which hinders the development of effective therapies for this comorbidity. The proposed studies attempt to identify molecular mechanisms underlying PIPN, as well as a potential therapeutic target to prevent the development of PIPN and neuropathic pain.